A mechanistic understanding of B cell and macrophage plasticity in lupus disease activity states

Project Summary/Abstract
Systemic lupus erythematosus (SLE) is a devastating autoimmune disease in which autoantibodies to ubiquitous
nuclear antigens cause inflammation and tissue damage in multiple organs. The treatment of SLE has improved
considerably over the past 30 years, but these advances have relied on existing medications with insufficient
efficacy and significant toxicities. Although several new therapeutics are now available, the new drugs are still
only modestly effective. It is imperative, therefore, that advances in immunologic knowledge be applied to
improve the treatment and quality of life of SLE patients by maintaining them in a remission state. Both B cell
activation and myeloid cell activation can drive SLE onset and flare, leading to our focus on these two immune
subsets and the period prior to flare in this proposal. Our Autoimmunity Center of Excellence proposal is centered
on the hypothesis that an improved understanding of the mechanisms that regulate disease specific immune
states that are perturbed during active disease or disease flare will form the basis for appropriate patient
stratification and selection for clinical trials and will provide insights into new therapeutic targets. Autoantibody
production is central to the pathogenesis of SLE but many questions remain about the origins of the plasma cells
that produce them. It is clear that autoantibody production can precede disease onset by many years, and that
flares of SLE are often associated with a new wave of plasma cell proliferation. The Principal Project (Dr. Betty
Diamond) will address what B cell pathways are associated with the tolerance state during disease quiescence
compared with active disease and healthy controls and whether B cell selection, activation or differentiation to
plasmablasts are affected during active disease and remission. A crucial tool is a new fluorescent nuclear antigen
preparation, developed by the Diamond group that can be used to identify and isolate autoreactive B cells that
represent only a small fraction of the total B cell population. One B cell subset of particular interest in SLE is the
non-classical ABC (age-associated B cell) subset that expands and produces autoantibodies and cytokines in
response to innate stimuli and can activate T cells through antigen presenting functions. The Pilot Project (Dr.
Sun Jung Kim) will address how ABCs take up and present antigen and what metabolic state is needed for their
T cell activating function. This may suggest strategies to modulate their state to treat active disease or prevent
flares. Activated monocytes are found in the blood of patients with SLE flares. The Collaborative Project (Dr.
Anne Davidson) will study disease specific monocyte cell states by sampling blood and urine and define those
cell states that are present in active disease or increase in frequency prior to disease flares. Our proposal is
bolstered by close scientific interactions among the three lead investigators, by the availability of legacy samples
from the previous ACE cycle, by collaborations with experts in next generation sequencing methods and data
analysis and by a robust clinical infrastructure that will add clinical depth and ensure timely recruitment of patient
cohorts that will be shared by all three studies.

Public health relevance
Narrative Systemic lupus erythematosus is a severe autoimmune disease in which antibodies to self- components cause inflammation in many organs. Current therapies for SLE are not effective enough and have many side effects. The focus of the Feinstein Institutes for Medical Research ACE project is to analyze the origins and mechanisms for expansion of the specialized immune cells that arise during flares of disease. These studies may then allow for the proper selection of patients for clinical trials of new treatments that target the relevant pathways to maintain the remission state.